Mechanisms of DUX4-induced misregulation of RNA processing and quality control

PROJECT SUMMARY
Facioscapulohumeral muscular dystrophy (FSHD) is a devastating muscle disease caused by the
inappropriate expression of an early embryonic transcription factor, DUX4, in the skeletal muscle. DUX4
activates hundreds of genes in muscle cells and eventually induces toxicity. Which of the DUX4-driven gene
expression changes underlie its pathogenicity is currently unknown. Our previous research has shown that
DUX4 significantly affects RNA metabolism in muscle cells. Specifically, DUX4 induces altered splicing and
proteasome-mediated loss of RNA quality control, with a resultant increase in aberrant transcripts that encode
potentially toxic, truncated proteins. Hence, we hypothesize that DUX4-induced misregulation of RNA
metabolism is a key driver of its pathogenicity in FSHD.
To test this hypothesis, we seek to determine the mechanistic underpinnings of how DUX4 increases aberrant
RNAs in the cell. We will do so by determining the mechanism of DUX4-induced aberrant splicing (Aim 1) and
identifying factors that induce loss of RNA quality control via the ubiquitin-proteasome system upon DUX4
expression (Aim 2). We will use a combination of biochemistry, genome engineering, proteomics, and
genomics to address these questions in a temporally controlled, inducible DUX4 expression system.
Successful completion of these studies will allow us to determine how DUX4, a transcription factor, rewires the
post-transcriptional gene regulatory network of muscle cells. Given that perturbed RNA metabolism is a
common mechanism underlying many muscle diseases, a better understanding of its role in FSHD could also
aid in novel therapeutic discovery.

Public health relevance
PROJECT NARRATIVE Misexpression of an early embryonic transcription factor, DUX4, in the skeletal muscle causes facioscapulohumeral muscular dystrophy (FSHD) through poorly understood mechanisms. This proposal aims to fill a critical gap in our knowledge of DUX4 pathobiology by investigating the mechanisms of misregulated RNA processing and quality control induced by DUX4. Our findings will pave the way to identify new therapeutic vulnerabilities for FSHD and other neuromuscular diseases caused by perturbed RNA metabolism.